Protein display drug ANDI reduces asthmatic airway hyperreactivity

ABSTRACT/SUMMARY
Causal role of FcRI-bound IgE on mast cells in IgE-mediated severe allergic asthma
Since the discovery of IgE and IgE-mediated mast cell degranulation by the Ishizaka’s in 1966, the deep
scientific challenge in IgE/mast cell research, is whether FcRI receptor-bound IgE, a central culprit for
proinflammatory small molecules or cytokines, may be dissociated by pharmacophores. Removal of receptor
bound IgE therefore eliminates en block a plethora of proinflammatory small molecules and cytokines is
therefore a treatment of choice. The affinity of receptor bound IgE is around 1 nM range. Thus, the first
generation Omalizumab, Xolair targeting at neutralizing and antagonizing free IgE sensitization to mast cells is
discovered in the laboratories in collaboration with Tse-Wen Chang at Tanox, Inc. Asthmatic exacerbation is
reduced in Xolair-treated patients; however, patients did not exhibit FEV1 improvement, despite 90% of
circulating free IgE is neutralized. Xolair does not directly access to the mucosal IgE in the lung. Moreover,
Xolair, which binds to regions of IgE distal to the receptor-binding C2-3, BC, DE, FG sites, is not capable of
dissociating receptor bound IgE from mast cells. Removing the chief culprit upon of receptor-binding IgE is an
urgent task to further reduce asthmatic exacerbation and restore FEV1. Thus, we investigate the bifunctional
IgE antagonist and dissociator (ANDI) to complement the monofunctional Xolair as a second generation of IgE
Therapeutics.
ANDI is safe to use in that E8 VHH which accommodates receptor-binding DE/FG receptor-binding sites in
camelid VHH nanobody (not a full complement of four receptor-binding IgE epitopes), does not spontaneously
activate mast cells. Moreover, the long-term use of ANDI E8 or E8H can be assured by its lack of
immunogenicity, highly homologous to human VH3, which is rendered further immune tolerant via the airway
administrative regimen.
ANDI is an innovative invention in that: (i) being a first-in-kind bifunctional IgE drug since 1966 to
antagonize as well as dissociate mast cell receptor-bound pathogenic pool IgE in contrast to the first generation
of Xolair; (ii) in that being the first IgE ligand-based camelid nanobody (humanized) that improves airway
hyperactivity (AHR) in an animal model, and offers a promise to improve FEV1 in humans; (iii) in that using
novel protein display platform to meet the challenge of improving potency and safety of the ANDI candidates;
(iv) in that removing receptor-bound IgE from mast cells arrests downstream plethora of proinflammatory
molecules and cytokines of mast cells, therefore improve lung function in asthmatic patients, reducing
morbidity and mortality.
Goal and Milestones:
Taken together, Aim 1 on ANDI humanization and Aim 2 on ANDI tolerance provide foundation of studying
long-term drugability of ANDI nanobody accomplish the Milestones in each respective Aim independently, as
well as interactively as applied to Aim 3 humanized animal model of asthma for safety and efficacies.
The three Aims contribute to the goal of a safe and efficacious innovative ANDI for its long-term use to treat
SA and improve lung function of SA patients.

Public health relevance
Layman Narrative Since the discovery of IgE and IgE-mediated mast cell degranulation by the Ishizaka’s in 1966, the deep scientific challenge in IgE/mast cell research, is whether FcRI receptor-bound IgE, a central culprit for proinflammatory small molecules or cytokines, may be dissociated by pharmacophores. This pursuit has not been fulfilled. Since dissociating receptor bound IgE eliminates en block a plethora of proinflammatory molecules and cytokine, it is necessary to innovate a treatment of choice. Omalizumab/Xolair can effectively neutralize and antagonize free IgE sensitization to mast cells, however it does Not dissociate receptor-bound IgE from mast cells. Herein, we intend to use a designed camelid VHH nanobody E8 and humanized E8H to antagonize IgE similar to Xolair as well as safely to dissociate receptor-bound human IgE from human mast cells in vitro and in HDM-sensitized human stem cell reconstituted rodent in vivo. Therefore, the proposed revised grant intends to elucidate the ANDI product concepts in the three Aims and delivers a safe and efficacious ANDI on the FDA roadmap.